Advancement of the Xiphophorus Model for Studying Disease

Project Summary
Xiphophorus fishes serve as long-standing biomedical models for translational research in multiple
disciplines. They are used widely in research topics that connect to the missions of multiple NIH
Institutions/Centers. Xiphophorus fish exhibit several features that no other animal model shares,
including high level of inter-species genetic divergence, capability of producing inter-species hybrids and
backcross hybrids, adaptive phenotypes representing human diseases. Recently accomplished genome
assemblies for several Xiphophorus species, in addition to the specialties of Xiphophorus model, provide the
premise to study non-biased assessment of genetics underlying complex traits associated with diseases in
humans. The primary goal of the Xiphophorus Genetic Stock Center (XGSC) is to maintain these unique
features and preserve the strength of this model to be used in biomedical research. The XGSC is not only a
resource center hosting many different species, but also the only center that preserves/maintains high level of
tractable genotypic and phenotypic diversity. The XGSC maintains 61 pedigreed lines that belong to 24
Xiphophorus species. It resides at Texas State University and has actively served a broad research
community since 1993. XGSC has a wide international impact. We provide pedigreed fish and material to
investigators in 30 laboratories of 11 countries. Herein this proposal, we focus on continuing successful
operation of the XGSC, enhancing animal husbandry, maintaining relevant resources, and providing
animal husbandry training for the research community, and student training for the host institution.
Proposed enhancement of Xiphophorus resources will leverage the disease-like phenotypes related to
cancer, metabolic disorders and the human disease-associated molecular phenotypes. Innovatively, we
will investigate on the cellular, tissue and organ level, the genetic signaling underlying (a) cancer progression
and (b) metabolic disorder/obesity. We will achieve theses goal by characterizing cell types involved in these
phenotypes on the molecular level which are critically involved in driving disease progression and by
deciphering epigenetic alterations during disease development. We will also (c) characterize alleles that
contribute to metabolic disorder formation. In addition, we will (d) expand disease related resources of
Xiphophorus by studying molecular traits that are associated with various types of human diseases, with a
primary goal of identifying molecular traits that can benefit early disease diagnosis and treatment. The
significance of achieving the goals in the proposal will be the support to continue to maintain irreplaceable
genetic resources and advancing our understanding on the molecular, cellular and organismic level of
genetic interactions associated with human health and diseases. The outcomes of the proposal can
forward our understanding of disease etiology, lead to novel therapeutic strategies, and identify causal or
regulatory alleles that may be utilized as predictors and targets in personalized medicine.

Public health relevance
Narrative Disease driver genes have been identified in the past few decades, advancing both mechanistic understanding of disease and therapeutic development. However, the genetic background impacts considerably on the phenotype of a specific disease. These effects are due to genetic background and/or environmental influence on the disease driver, complicating diagnosis and proper treatment selection. Therefore, it is of utmost importance and relevance to investigate genetic background effects on disease development and progression. We now understand that genetic background effects are due to epistatic interactions that modulate disease driver function. However, common animal models are not suitable for studying this question because laboratory strains of these animals are mostly inbred and selected for laboratory use. Because they are closely related and at best represent different populations of just one species, they do not constitute high enough genetic diversity to allow identification of modulating epistasis. To circumvent this hurdle, we propose to implement various Xiphophorus fish species. These species present high inter-species phenotypical and genetic variation and harbor natural alleles that are disease associated. They offer the possibility of producing artificial inter-species hybrids, providing the unique possibility to investigate epistasis underlying diseases including cancer, metabolic disorders and aberrant disease related molecular traits. This suitability makes Xiphophorus the experimental model organism of choice to fill a knowledge gap in disease model research and to develop innovative research strategies. Xiphophorus is a genus of live-bearing freshwater fish that includes 26 species. The Xiphophorus Genetic Stock Center is a national resource center that hosts 61 pedigree lines that belong to 24 species. The goal of the XGSC is to maintain the unique features and preserve the strength of this model to be used in biomedical research.